Immune drivers of oncogenic virus progression to cancer in people living with HIV

PROJECT SUMMARY/ABSTRACT
The overarching goal of my research is to improve prevention, early detection, and outcomes of infection-
related cancers, particularly among people living with HIV (PHIV) who experience an increased burden. Due to
the immunosuppression and aberrant immune activation that accompanies lifelong HIV infection, PHIV have a
higher prevalence of oncogenic infections (i.e. HPV) and those infections are more likely to persist and
progress to cancer (i.e. cervical, anal, and oropharyngeal). My hypothesis is that systemic immune
dysregulation is associated with an inability to control oncogenic infections and exacerbated in PHIV. Under
this Catalyst Award, I plan to grow my research in the distinct direction of understanding the immune drivers of
persistent oncogenic infections. To address this, I propose to start by utilizing a novel application of genome-
wide DNA methylation. This recently published method can determine a person’s immune cell profile
comprised of 12 immune cell subsets from the methylation array data, which can provide information on their
overall immune function, which can then be investigated for its association with persistent oncogenic infections
and progression to cancer. The first project I propose towards this goal will utilize specimens already available
or currently being collected to investigate the immune drivers of oral HPV persistence, the pre-cursor to
oropharyngeal cancer (OPC) by assessing the association between host immune cell profile and persistent
oral hrHPV. Oropharyngeal cancer (OPC) caused by oral human papillomavirus (HPV) infection is increasing
in incidence globally with a burden of disease disproportionately distributed among men and PHIV. A persistent
oral high-risk HPV (hrHPV) infection has been identified as the obligate precursor to HPV-associated OPC
(HPV-OPC) and can be utilized as a study endpoint. Therefore in this first study, methylation-based immune
profile will be compared by oral HPV persistence status to understand the degree of immune function among
study participants and its association with oral hrHPV persistence. I will then plan to repeat these methods for
investigation at other HPV-related anatomic sites among the same participants and in other cohorts I serve as
investigator. With a research background in basic science and molecular epidemiology I will be able to
integrate multiple sources of data using a novel epigenetic tool not previously used to investigate persistent
oncogenic infections among PHIV. My prior work has pursued overarching research interests within HPV-
associated cancer or cancer among PHIV. The new direction of my research has a foundation in my prior work
and expertise but represents movement in a new direction with a focus in immuno-oncology to gain insight into
the immune drivers of persistent oncogenic infection that progresses to cancer among PHIV.

Public health relevance
PROJECT NARRATIVE With rates of oncogenic viral infections higher in people living with HIV (PHIV) there is a need to understand the immune drivers of persistence of such an infection before it progresses to cancer. A novel derivation of a widely available assay was recently produced and is proposed here as an innovative way to first, evaluate oral HPV persistence in PHIV and then expanded for utilization at other HPV-related anatomic sites and within the scope of other oncogenic infections. As immuno-oncology is a relatively new area of research in the study of oncogenic virus progression to cancer, the results of these studies would inform design of future research in the field, including the use of immune markers.